Platelet-MLKL role in S100 Release with Age and Infection

Project Summary
Advanced age is a single risk factor for developing serious complications from infections with respiratory viruses
such as influenza, SARS-CoV-2 or RSV. These complications are reflected in thrombotic outcomes including
microthrombosis, myocardial infarction and pulmonary embolism. The actual cause and mechanisms of these
thrombotic outcomes remains elusive. Pathogen spreading and crossover of these viruses into the circulation is
regulated by various mechanisms, some of which involve lytic programmed cell death pathways such as
necroptosis executed by membrane channels formed by oligomerized phosho-Mixed Lineage Kinase Domain
Like Pseudokinase (MLKL). Platelets express MLKL, have a plethora of immune-sensing viral receptors and are
the major blood component responsible for thrombotic outcomes. We have shown that respiratory viral RNA can
be found in circulating platelets from influenza patients and preliminary result support channel formation. In this
proposal, we hypothesize that platelet-pMLKL channel formation, mediated by influenza, leads to cytoplasmic
S100 content release and contributes to immunothrombosis with age. We propose to test this hypothesis with
the following aims: 1. Determine the MLKL-specific platelet content release and whether platelets undergo
necroptosis as a result of influenza and (or) age, and 2. Determine the contribution of age to MLKL-activation
and immunothrombotic aggregates during infection. The proposed studies are central to elucidating mechanisms
that may increase immunothrombotic risk and adverse cardiovascular outcomes beyond classical platelet
activation, with advanced age, and provide a basis for novel and targeted treatments for prevention.

Public health relevance
PROJECT NARRATIVE Managing the impact of thrombosis and coagulation is central to improving complication survival as a result of advanced age during respiratory viral infections. This exploratory research proposal aims to investigate the role of platelet MLKL-necroptotic channel formations in S100 release and immuno-thrombotic outcomes with age. Defining the mechanisms that lead to MKLK-activation of platelets and how those mechanisms lead to increased release (independent of classical platelet agonists) of proteins related to inflammation and immuno- thrombosis, will enable us to design therapies for aging individuals, that can imporve thrombotic outcome beyond classical antiplatelet drugs.